Sexual harassment Training Of Principal investigators (STOP)

PROJECT SUMMARY
Despite high enrollment in medical school and graduate programs, women remain under-represented in the
biomedical research workforce. NIH T32 training programs are an understudied yet important contributor to the
biomedical research workforce and are a key stage at which we can intervene. While roughly half of trainees
covered by T32 grants are women, women remain underrepresented amongst those earning extramural
research support. Given its prevalence in both medicine and science, sexual harassment is likely a contributor
to this disparity. Data from the National Academies of Sciences, Engineering, and Medicine describe the
damage caused by sexual harassment, ultimately leading to a costly loss of talent as women, particularly
women with intersectional identities, and sexual and gender minorities leave. The drivers of sexual
harassment, including factors and conditions that allow it to thrive, have been described with a conceptual
model incorporating an iceberg as a metaphor. The vast majority of sexual harassment, this model contends, is
the portion of the iceberg that is invisible under water. Because of this, many do not fully perceive the
prevalence of sexual harassment; however, the behaviors described in this model are damaging whether they
are visible (i.e., above water) or not. Despite these data, it is not yet clear what interventions can effectively
decrease the occurrence of sexual harassment. Newer interventions, such as civility and upstander
interventions, have been recommended by the Equal Employment Opportunity Commission but have not been
rigorously tested. Data suggest that interventions that go beyond sexual harassment alone and address other
related issues, such civility and upstander interventions, may be more effective than sexual harassment
training alone. We will conduct a randomized, controlled trial of NIH T32 programs to test whether a multi-
modal virtual intervention incorporating video game elements can increase T32 Principal Investigators’ and
mentors’ confidence in their ability to intervene when they hear about or see sexual harassment and increase
their knowledge on these topics. Furthermore, we will test the impact of the intervention on their mentees’
experiences with microaggressions and sexual harassment, sense of belonging, well-being, research
productivity, and persistence in a biomedical research career. Finally, we will test whether the intervention
improves the culture and climate of the learning environment. Rigorous evaluation of a virtual interactive
intervention to address and reduce sexual harassment for NIH T32 trainees can result in a generalizable and
easily scalable educational program to improve NIH training environments nationwide and ultimately improve
the diversity of the biomedical research workforce.

Public health relevance
PROJECT NARRATIVE A landmark report from the National Academies of Sciences, Medicine, and Engineering demonstrated the high prevalence of sexual harassment in medicine and science, which they conclude leads to a costly loss of talent. In a cohort of NIH T32 training programs, we will test whether a multi-modal virtual intervention with video game elements, developed from the NASEM conceptual model of sexual harassment, will increase Principal Investigators’ and mentors’ confidence in their ability to intervene and improve the culture and climate of the learning environment for NIH T32 funded mentees. We will also test whether the intervention improves civility, decreases rates of microaggressions and sexual harassment, and leads to a greater sense of belonging, well-being, research productivity, and persistence in a biomedical research career among NIH T32 mentees.